Clinical Protocol and Data Management

ABSTRACT
Overview: The Clinical Protocol and Data Management (CPDM) provides central administration and oversight
functions for coordinating, facilitating, and reporting on clinical and population sciences trials across the UCCC
clinical sites serving the catchment. The Data Safety and Monitoring Committee (DSMC) provides a robust
structure for auditing clinical trials across the UCCC partner sites. DSMC's oversight is prioritized for high-risk
Phase I and Phase II protocols. Accomplishments: Since 2016, the CPDM substantially improved clinical
research support as follows: 1) Investigator-initiated trial (IIT) support leading to a 411% increase in IIT accruals
from 2017-2020 compared to the previous similar period of 2013-2016; 2) Development of the Oncology Clinical
Research Support Team (OCRST). OCRST provides centralized SOP development, staff and investigator
training, multi-site coordination, and streamlining of processes for the successful implementation of clinical
research protocols across the network; 3) Expansion of the Front Range Clinical Trials Network (FRCTN)
provides clinical trial access to the population of Colorado. The inclusion of 5 UCHealth System clinical research
sites in the FRCTN presents an enormous opportunity for clinical and population health research given the size
and diversity of the socioeconomic demographics of the population and its rural/urban mix; 4) CPDM and
UCHealth implemented the Via Oncology Pathways across the UCHealth system with clinical trials built into the
pathways to ensure awareness and access to UCCC clinical trials across the catchment area. Quality Control
and Training: The CPDM initiated an educational curriculum to provide a cohesive and relevant training
structure to new staff and faculty and ongoing education to ensure those involved in the conduct of clinical
investigation remain knowledgeable of policies and regulations. A new curriculum was developed that utilizes
educational resources within the UCCC, UCAMC, the Colorado Clinical and Translational Sciences Institute
(CCTSI, UL1TR001082) and enhanced by feedback received from trial audits. Trials and Catchment Area
Demographics: The CPDM oversees an annual average of 527 clinical research studies. In FY2020, 608
patients were accrued to intervention-treatment studies. Patients seen at UCCC come from all 64 Colorado
counties. Based on data from 2020, patient accruals were consistent with the state cancer demographics. UCCC
has a plan to increase Hispanic enrollment to at least 10% and improve clinical trial access to the population at
large. Taken together, these data demonstrate substantial progress in the CPDM and further demonstrate the
UCCC's commitment to patients with cancer.